UNC Neuroscience Center Research Cores: Bioinformatics

PROJECT SUMMARY-BIOINFORMATICS CORE
The Bioinformatics Core analyzes high-throughput sequencing (HTS) datasets for NINDS-funded and other
NINDS-priority investigators at UNC. The Bioinformatics Core leverages Center grant support from NINDS, an
Intellectual Disabilities Research Center (IDDRC) grant from NICHD (awarded to the Carolina Institute for
Developmental Disabilities; CIDD), and Institutional support from the Lineberger Comprehensive Cancer
Center (LCCC). This core serves NINDS-funded and priority faculty, CIDD faculty who study
neurodevelopmental disorders, and LCCC faculty who study brain cancers. Support for the Core Director is split
50:50 between NINDS/CIDD and LCCC, while two additional bioinformaticians (TBN) will be supported, one by
NINDS/CIDD (50:50) and the other by LCCC (100%).